Project 5: Microencapsulation Delivery Vehicles for the Implementation of Precision Bioremediation at PAH-Contaminated Superfund Sites

Abstract
Polycyclic aromatic hydrocarbons (PAHs) are contaminants of great concern due to their toxic, mutagenic and
carcinogenic properties that are commonly encountered at Superfund sites. Due to their chemical characteristics,
PAHs tend to be highly hydrophobic and recalcitrant, making them challenging targets for remediation. PAH-
impacted sites are also frequently enriched with toxic metals from related industries, and such mixtures require
engineering solutions that effectively target PAHs while minimizing deleterious environmental impacts on co-
contaminants. Treatments in multi-contaminant settings are particularly challenging because bioremediation
strategies aimed at PAHs can introduce environmental conditions such as oxic microniches that may enhance
the leaching potential and bioavailability of metals. Because of these challenges, site managers often resort to
drastic remediation approaches such as soil excavation or dredging, which can have significant negative long-
term impacts on local ecosystems. In situ bioremediation has been widely studied as an alternative approach
with minimal ecological disruption. During the last funding period, we developed a generalizable framework for
the precision bioremediation of PAHs that harnesses in situ cross-kingdom microbial interactions. We created a
library of fungal and bacterial strains that could work cooperatively to breakdown PAHs. Yet, while strain selection
is a pivotal decision to be made for the effectiveness of the amended microbes, the observed transience of some
augmented strains after inoculation can significantly reduce the long-term effectiveness of bioremediation. Thus,
a particular challenge that remains to be solved is the long-term survival and activity of augmented exogenous
strains under complex site conditions. Herein, we propose to address this challenge by developing microbial
encapsulation delivery vehicles that enable targeted delivery and increased fitness of key microbial strains for
the implementation of precision bioremediation. The permeability of the microcapsule, alongside the protective
separation of the internal organisms from the external environment, makes microcapsules attractive for
deployment to natural environments and for the implementation of precision bioremediation. We hypothesize
that the use of microcapsules will improve delivery, viability and fitness of the augmented microbes thereby
improving PAH biodegradation. The specific aims for this project are to: 1) Optimize microcapsule synthesis for
delivery to soil and sediment sites, sorption of target PAHs, and growth/function of encapsulated microbes; 2)
Develop site-specific encapsulated microbial consortia of PAH degraders and compare to pure cultures for PAH
degradation; and 3) Investigate unintended impacts of the microencapsulated bioaugmentation strategy through
evaluation of PAH degradation products and geochemical transformations of co-contaminant metals in
Superfund-relevant conditions. Ultimately, this project will yield field translatable approaches for the
bioremediation of PAHs at Superfund sites with co-contaminants.

Public health relevance
Project Narrative Polycyclic aromatic hydrocarbons (PAHs) are contaminants of great concern commonly encountered at Superfund sites. In this project, we will develop innovative precision bioremediation approaches that promote PAH degradation and minimize co-contaminant mobilization. A fundamental feature of our project will be the engineering of microcapsule delivery vehicles that facilitate targeted delivery and optimized activity of microbes carrying out key remediation functions, ultimately reducing the potential for human and environmental exposure.